A Feasibility and Efficacy Study of NeuroTrainer Cognitive Training in Students With and Without Attention-Related Difficulties

Abstract
Attention Deficit Hyperactivity Disorder (ADHD) affects approximately 11% of children and adolescents, leading
to impairments in cognitive functions and decreased academic performance. Cognitive training presents a
promising non-pharmaceutical intervention for ADHD, although the benefits often exhibit limited transfer to
real-world tasks. This study aims to address this gap by testing a virtual reality (VR) cognitive training approach
called NeuroTrainer, which integrates physical activity, prolonged training near performance threshold, and
variability in task dynamics and demands. These factors are shown to be key for transfer success in diverse
populations. VR technology provides immersive, ecologically valid, and physically engaging environments that
motivate and engage students' attention.
Preliminary testing of NeuroTrainer has shown feasibility in school-based settings and potential efficacy for
students at risk for ADHD. The current proposal seeks to develop a commercially viable VR cognitive training
intervention for students with ADHD and aligned with National Institute of Mental Health (NIMH) strategies and
funding topics. The study will focus on improving attentional and executive control function (Aim 1), evaluating
efficacy of NeuroTrainer to engage the target of ADHD inattention symptoms (Aim 2), and demonstrate transfer
of skill with improvement in academic behaviors (Aim 3) within a sample of 155 students in school settings.
The primary outcome measures are effect sizes for attentional and executive control function, clinical
inattention symptoms, and academic behaviors (classroom engagement and attentiveness) in both ADHD and
non-ADHD groups. By leveraging VR technology, this study aims to contribute to the development of an
innovative, accessible, and effective intervention for ADHD students and a supplementary tool for others, with
potential for broad dissemination and applicability in diverse contexts.

Public health relevance
Narrative Our project introduces NeuroTrainer (NT), a novel virtual reality (VR) cognitive training system—which uniquely combines immersive VR technology with physical activity to enhance cognitive functions like attention and executive control, addressing both ADHD symptoms and related academic impairments—to address the challenges of ADHD, which affects about 11% of children and adolescents. This intervention aligns with NIMH goals by offering an engaging, adaptive, and personalized approach, aiming to improve real-world functional outcomes in educational settings. Our research aims to demonstrate NT's effectiveness in enhancing cognitive and academic performance, potentially transforming ADHD intervention methods and contributing to better mental health outcomes.